HLA-DO / H2-O: modulation of MHC-II peptide diversity and Treg population control

HLA-DO / H2-O (DO) is a non-classical MHCII protein that functions as a specific competitive inhibitor of the
peptide exchange factor HLA-DM / H2-M (DM), regulating peptide loading onto MHCII molecules in antigen-
presenting cells. During CD4 T cell development, thymocytes are selected for conversion to conventional naïve
CD4 T cells or self-tolerant regulatory T cells, or are deleted by negative selection, depending on the strength
of interaction with MHCII-bound peptides displayed on antigen presenting cells in the thymus. We eluted
peptides from wild-type C57BL/6 and DO-knockout thymus, and found alterations in the spectrum of peptides
presented by MHCII molecules. We examined CD4 T cell development in DO-deficient mice, and found
alterations in Treg number and function, and increased sensitivity to viral infection. The overarching hypothesis
of this proposal is that DO regulates antigen presentation by restraining the peptide editing activity of DM in
order to allow a broad representation of peptides presented at the cell surface, and this activity is essential for
proper thymic selection of self-tolerant conventional and regulatory T cells. There are two specific aims. Aim 1
is to evaluate the role of DO-dependent antigen presentation in selection of CD4 Tconv and Treg populations.
We will identify peptides differentially presented in the thymus in the presence or absence of DO, follow
individual TCR clonotypes as they undergo thymic selection in WT and DO-KO TCR-restricted mice, combine
these results to identity DO-peptides responsible for Treg skewing, and finally characterize functional effects of
Treg dysregulation in DO-KO mice. These experiments will test the hypothesis that narrowing of the peptide
repertoire presented by MHCII molecules induced by deletion of DO results in altered thymic selection and
peripheral regulation of regulatory T cells. Aim 2 is to determine the role of HLA-DO / H2-O in regulating Tconv
and Treg populations in an infection model. We will evaluate the functional consequences of DO-induced
changes in the TCR repertoire and activation state of CD4 T cell populations in the response of BL/6 mice to
primary influenza infection. Tregs have been shown previously to regulate CD4 and CD8 T cell responses and
recruitment of innate effector cells, and we observe alterations in these effects in DO-KO mice, suggesting a
dysregulation of Tregs in the absence of DO. We will test this hypothesis, using a FoxP3-DTR system to swap
Treg compartments between mice. A second part of this aim is to evaluate the functional consequences of DO-
induced alterations in antigen presentation and TCR repertoires using the influenza infection model. The long-
term goals of this project are to define how control of DM-mediated peptide editing by DO regulates selection
of self- and pathogen-derived peptides displayed on MHCII, and to decipher the impact of DO-regulated
peptide presentation on the development and function of the CD4 T cell repertoire.
1

Public health relevance
Effective immune responses require a balance between effector T cells, which help to clear pathogens and tumor cells, and regulatory T cells, which restrain these responses to prevent autoimmunity and immunopathology. Both types of cells arise from the same precursor population, with differentiation into the two lineages driven in part by different signals that they receive from peptides presented by major histocompatibility molecules. The proposed research will evaluate a role for a non-classical major histocompatibility protein in regulating the antigen processing pathways that generate the peptides responsible for directing developing T cells into effector or regulatory lineages.